PORCINE FETAL NEURONAL CELLS FOR TRANSPLANT INTO PARKINSON'S DISEASE

The purpose of this protocol is to determine the safety of porcine fetal neuronal cell implantation into the putamen and caudate of patients with Parkinson's diseasue, under two different methods of manipulating the human immune system to prevent rejection of the transplanted tissue.